Adults with Fragile X Syndrome: Health and Life Course Trajectories

This is a continuation application for an additional 5 years of support for a comparative and prospective study of
Fragile X Syndrome (FXS), an inherited neurodevelopmental disorder caused by a trinucleotide expansion of
CGG repeats in the FMR1 gene on the X chromosome. FXS results in significant health and functional
impairments that begin in early childhood and last a lifetime. It is the most common inherited cause of intellectual
disability and autism, with substantial family burden and public health impacts. Critically, the great majority of
knowledge about the FXS clinical phenotype derives from research on children, leaving adulthood a vast
uncharted territory. The purpose of the proposed research is to investigate how the health and behavioral
functioning of individuals with FXS change across adulthood and to identify factors that alleviate or worsen health
and behavioral functioning during the adult years. It will be the first study to robustly address these questions
beyond early adulthood. We address 3 Specific Aims. For Aim 1, we will determine profiles of health conditions
and health care utilization for adults with FXS. Using a case-control design, we propose to examine the health
of a newly ascertained cohort of 368 adults (age 18 to 80+) who have a code for FXS in their electronic health
records (EHRs) – 162 women, 206 men, 77 nonwhite, and 291 white. These adults will be drawn from 11 health
care systems comprising the Chicago Area Patient-Centered Outcomes Research Network (CAPriCORN). Using
EHRs, we will examine differences between adults with FXS and age- and sex-matched controls who do not
have FXS with respect to health and health care utilization. We will probe differences between sub-groups of
adults with FXS defined by age (early adulthood, midlife, older adulthood) as well as by sex and race. For Aim
2, using a longitudinal design that will span 18 years, we will define life course trajectories in health and
behavioral functioning among adults with FXS and investigate age-related risk. Building on the 5 already-
collected repeated measures, we will prospectively gather 3 additional rounds of data, resulting in up to 8
repeated measures over the 18-year period (n=182 dyads of adults with FXS and their premutation carrier
mothers). By the end of the proposed study, the adults in our existing longitudinal sample will average 37 years
of age, with 59% being age 35 or older (the oldest will be age 72). We will employ an accelerated longitudinal
design to elucidate changes in health, executive functioning, communication, behavior problems, and daily living
skills across adulthood. We will test for ages of increased risk and the effects of sex and autism on these
trajectories. For Aim 3, using the same sample as in Aim 2, we will examine how life course trajectories of adults
with FXS are associated with familial and social contextual determinants – family relationships, residential status
of the adult with FXS, educational level of parents, family income, type of health insurance, services, and
neighborhood SES. By employing multiple innovative methods and varied data sources, the proposed study will
extend knowledge about FXS beyond early adulthood and elucidate how FXS changes in midlife and beyond.

Public health relevance
Fragile X Syndrome (FXS) is an inherited, lifelong neurodevelopmental disorder that results in significant health and functional impairments; however, the great majority of knowledge about FXS derives from research on children, leaving adulthood a vast uncharted territory. In this proposed renewal, we will investigate FXS during adulthood and we will evaluate how the family and social contexts are associated with more favorable health and behavioral functioning during this life stage. We will leverage two distinct and rich data sources– electronic health records drawn from a racially and ethnically diverse population of 15 million patients in the Chicago area which includes 368 adults (age 18 to 80+) with FXS, and a separate longitudinal cohort of adults with FXS and their premutation carrier mothers (n=182 dyads) with up to 8 repeated measures over the 18- year period.